The University of Chicago and Northwestern University Postdoctoral Health Services Research Program

Project Summary
Because of widespread concerns about health care quality and safety, disparities in access and outcomes for
vulnerable populations, and the desire to rapidly move evidence-based therapies into practice, there is a critical
need to train and develop a highly competent, multidisciplinary workforce of future leaders in health services
research (HSR). This application proposes to build on a nine-year history of successful joint training programs
and research collaborations to launch a new University of Chicago And Northwestern University Postdoctoral
HSR Program, referred to as the “UCANU Postdoctoral HSR Program”, which will use an innovative,
competency-based curriculum to train candidates from diverse personal and professional backgrounds in
traditional HSR, learning health system methods, implementation science, health disparities research, data
science, and systems science. Our robust, comprehensive training architecture incorporates didactics, mentored
research, and professional development activities that maximize the complementary strengths of University of
Chicago (UC) and Northwestern University (NU) in the diverse metropolitan city of Chicago. Together, we will
train the next generation of health services researchers who will conduct and lead rigorous, reproducible health
services research using both experimental and observational study designs and quantitative, qualitative, and
mixed methods research. To achieve this goal, we will: (1) administer a two-institution (UC and NU) training
program that integrates numerous complementary resources for training and career development, including
didactics, conferences (including joint seminars with all UCANU trainees and faculty), mentoring, and other
professional development activities; and (2) leverage the exceptional expertise of faculty mentors at both
institutions to ensure that fellows attain the knowledge, skills, and experiences required to transition into careers
that sustain innovative, independently-funded health services research. Our program will invite applications from
a diverse pool of candidates who have completed a PhD or clinical doctoral training and residency or fellowship
(e.g., MD, DPT), and it will support the training of four positions per year (two at UC, two at NU). Fellows will
have their primary home at the institution that best fits their needs for faculty mentorship and training, including
access to graduate degree programs. Fellows may earn a Master of Science in Public Health Sciences for
Clinical Professionals at UC or a Master of Science in Health Services and Outcomes Research at NU. An
advisory board will oversee all training along with a Postdoctoral HSR Program Steering Committee that
intentionally includes leadership and faculty mentors from both NU and UC to optimize coordination and
collaboration between the two sites. Over the next five years, we will leverage the vast, remarkable strengths of
our combined universities to train and prepare the next generation of diverse scientists whose careers will employ
the power of rigorous and innovative HSR to improve healthcare delivery and access, increase implementation
of evidence, maximize health outcomes, and eliminate health disparities.

Public health relevance
Project Narrative The University of Chicago And Northwestern University Postdoctoral Health Services Research Program, application referred to as the “UCANU Postdoctoral HSR Program,” proposes a multi-institutional, competency-driven postdoctoral training program that will use mentored research, didactics, and professional development activities to train social scientists and clinicians in health services research, implementation science, learning health system methods, health equity and disparities research, systems science, and data science. We aim to develop future leaders whose careers will increase implementation of evidence-based practices, reduce health disparities, and improve health care organization and delivery in the United States.